Sperm epigenetic diagnostic to inform couples time to pregnancy

SUMMARY
This application is for an STTR phase I project aimed at developing a sperm-specific test to predict the time it
takes for couples to conceive. Infertility is one of the most common reproductive health disorders, affecting 17%
of couples in the U.S. Notably, infertility has historically been treated as a female issue; however, around half of
all infertility cases are partially or completely attributed to male factors. Clinical male infertility is typically
ascertained based on semen-quality reference values established by the World Health Organization (WHO)
criteria; however, these criteria are poor predictors of reproductive success, raising questions about the
significance and reliability of conventional methods for evaluating male fertility. Despite significant advances in
understanding the molecular characteristics of semen, measures of male fertility have remained unchanged for
decades. Therefore, the development of novel biomarkers of male reproductive health is vital to improving
reproductive clinical care. Spermatogenesis requires dynamic reprogramming of the epigenome to enable the
progression from diploid spermatogonia to haploid mature spermatozoa. We propose that the robust epigenetic
reprogramming during spermatogenesis provides a final opportunity for sperm to “epigenetically match” with their
internal factors (e.g., genetics) and external factors (e.g., environment) prior to conception. In recent years,
epigenetic clocks, which estimate biological age, have been developed as novel biomarkers for phenotypes such
as cancer and mortality. Importantly, our group was the first to develop a sperm-specific epigenetic clock, which
has been associated with couples’ pregnancy outcomes and validated in an independent infertility cohort. This
application will leverage our machine learning pipeline and extant sperm methylation data, along with
reproductive outcome data from 1,825 couples from both the general population and infertility cohorts, to further
optimize and validate a new sperm epigenetic clock that predicts reproductive outcomes. The research proposed
in this application will optimize and validate our prediction models across three distinct cohorts, demonstrating
the feasibility of our product as a potential male fertility diagnostic tool to inform clinical decision-making and
support the management of couples seeking to achieve pregnancy in both clinical and non-clinical samples.

Public health relevance
NARRATIVE Male factor infertility is responsible for up to 50% of cases of couple infertility; however, diagnostic tools for male infertility and reproductive success remain limited. Thus, the development of novel biomarkers for male reproductive health is vital to improving clinical care and reproductive outcomes. This project proposes to develop a sperm-specific DNA methylation index that predicts both the time it takes for couples from the general population to conceive and the likelihood of success for couples undergoing infertility treatment.